PROTO-ONCOGENE EXPRESSION DURING LENS DIFFERENTIATION AND DEVELOPMENT

This project investigates the expression of proto-oncogenes during the differentiation of embryonic lens epithelial cells to form lens fiber cells, and seeks to determine the specific function of the corresponding gene products in the developing lens. Using radioactively labeled DNA probes we have demonstrated that levels of c-myc mRNA are transiently elevated during the first few hours after the initiation of differentiation in vitro. The elevation of c-myc mRNA seems to be post-transcriptionally regulated, as determined by a small-scale nuclear run-on transcription assay developed in this laboratory, which allows measurements to be made on as few as 106 cells. Inhibitors of the lipoxygenase pathway of arachidonic acid metabolism produce a similar elevation of c-myc mRNA, which also seems to be post- transcriptionally regulated. Analysis of the arachidonic acid metabolites synthesized by differentiating lens epithelial explants has confirmed that elevated c-myc mRNA levels are correlated with the disappearance of a specific lipoxygenase pathway metabolite.